How Cd1d protects mice during natural infection

Summary
Natural killer T cells (NKT) are a special class of lymphocytes that recognize lipid antigens presented by CD1
family molecules. They are strongly conserved throughout mammalian evolution. Nonetheless, we do not
understand what essential function(s) lipid specific T cells serve to promote the health of the species.
To determine if there is a common mouse microorganism that NKT cells play a role in protection from, we co-
housed CD1d deficient mice with pet store mice, which bear a relatively high natural microbial burden, to
permit physiological transmission of microbes. Adult CD1d deficient mice were generally healthy when co-
housed. However, CD1d deficient pups did not survive to term in Cd1d+/- x Cd1d+/- breeding cages where
there was normal microbial exposure (i.e. only WT or CD1d heterozygous pups survived). This suggests the
hypothesis that NKT cells play a critical role in protecting the developing fetus in the face of diverse
microbial infection and may explain their conservation throughout mammalian evolution. This is an exciting
new finding and important hypothesis to test. However, key information is required before mechanistic R01
type research can be proposed. In this R21 proposal, we seek to understand whether maternal NKT cells are
activated by fetal (trophoblast) CD1d and required for protection of the fetus, and if fetal demise is associated
with excess inflammation and/or a specific microbial infection.

Public health relevance
Narrative Natural killer T cells (NKT) are a special class of lymphocytes that recognize lipid antigens as opposed to peptide antigens that conventional T cells recognize. Preliminary data suggests they are involved in protecting the developing placenta from damage during microbial infection. This research is highly relevant to understanding the evolutionary importance of this lymphocyte subclass. It ultimately may inform what causes miscarriage, growth restriction, and pre-term birth in humans.